RADx Innovation Funnel for Hepatitis B Diagnostics – Commercialization Center

The goal of the Commercialization Center for the RADx Innovation Funnel for Hepatitis B (HBV) Diagnostics is to accelerate regulatory review and availability of high-quality, accurate, and reliable diagnostic tests to the public. The Commercialization Center will provide technical, clinical, and commercialization expertise and resources to this RADx effort seeking to accelerate the deployment of point-of-care diagnostic technologies for HBV. The Commercialization Center is a trans-NIH focused activity that provides professional services support across a range of commercialization domains to NIH translational activities.